The Boston Lung Cancer Survival Cohort

The Boston Lung Cancer Survival (BLCS) cohort is a Cancer Epidemiology Cohort of more than 12,000 lung
cancer cases enrolled at Massachusetts General Hospital and the Dana-Farber Cancer Institute since 1992.
This rich resource enables research to understand lung cancer heterogeneity that has already identified
valuable prognostic markers and stimulated new treatment strategies. For example, the BLCS supported the
first discovery of the association between EGFR mutations and response to therapy with EGFR-tyrosine kinase
inhibitors and enabled research on effective treatments for non-small cell lung cancer patients with ALK and
ROS1 rearrangements. In 2017, the cohort evolved into a survivor epidemiology cohort that is sustained by a
U01 grant until May 2023. Our progress during the first U01 funding cycle (2017–2022) is substantial—we
have published over 100 papers, supported 6 new grants, and worked with 50 collaborators nationally and
internationally. With the U01 award expiring soon, there is an urgency to renew to: 1) maintain this first and
most comprehensive lung cancer survivor cohort with the longest follow-up period—an unmatched source of
data for translational research; 2) establish an innovative, detailed phenotyping database via automated image
analysis of high-resolution computed tomography, as well as a radiomics database; 3) enable the established
infrastructure to facilitate internal and external investigators to pilot methodologic approaches that will turn into
productive multidisciplinary project grants by focusing on survival and treatment toxicity; and 4) leverage the
Dana-Farber/Harvard Cancer Center Lung Program resources for creative multidisciplinary collaborations
focused on treatment outcomes. Renewed funding is also critical to recruit 2,500 new cases (for a total of
14,500 cases) to this already large cohort. New cases are vitally important to: 1) facilitate comparison of new
treatments and traditional therapy as well as evaluation of new clinical investigation in an ever-changing
therapeutic environment; 2) allow us to collect more cases with driver mutation data, as well as those treated
with immune checkpoint inhibitors; 3) promote collection of repeated biological samples to support developing
prognostic/predictive biomarkers; 4) allow us to collect detailed data enabling assessment of environmental
determinants as well as racial and socioeconomic determinants of survival; and 5) empower our studies to
identify radiomic, genomic, epigenetic, and other phenomic biomarkers, environmental determinants, and racial
and socioeconomic determinants that are relevant to patient survival to guide improved lung cancer screening
and treatment strategies. The BLCS is one of the largest lung cancer survival cohorts and encompasses a
wealth of biomarker, tumor molecular characterization, imaging, lung function, genetic, epigenetic, traditional
epidemiologic risk factor, and electronic health record data. With continued support, this comprehensive cohort
will provide unique opportunities to explore predictors of lung cancer survival and treatment outcomes,
catalyzing powerful translational research that improves the health of individuals with lung cancer.

Public health relevance
The Boston Lung Cancer Survival cohort contains an extensive amount of valuable questionnaire and biologic data that can be leveraged to extend our understanding of the natural history of lung cancer. The combination of biomarkers, tumor molecular characterization, radiomic features, and traditional epidemiologic risk factors in this rich resource enables powerful translational research and provides unique opportunities to explore novel predictors of overall survival and treatment outcomes. With continued support, the Boston Lung Cancer Survival cohort can continue to advance our understanding of the molecular heterogeneity of lung cancer, enabling effective diagnostic and therapeutic strategies that improve the health of individuals diagnosed with lung cancer.